Regulation of apicomplexan mitosis coupled to budding

Abstract
Apicomplexan parasites contribute significantly to the human disease burden, including Plasmodium spp.
infection causing ~400,000 deaths per year, and Toxoplasma gondii permanently infecting about ~1/3 of the
human populations. Existing treatments are limited, which fuels studies that aim to uncover new vulnerable
processes to control such infections. Our project investigates the core survival mechanism that controls parasite
division taking place in its host, the cell cycle. Apicomplexan cell division differs vastly from that of their host
cells, and represent a remarkably versatile, novel, and poorly understood biological process. Some
apicomplexan species replicate their genome once per division cycle (binary division) and produce two progeny,
while the majority of species instead replicate their genome multiple times (multinuclear division) and produce
thousands of daughter cells in a single round of division. The variety of replication modes, dearth of conserved
conventional regulators, and the complexity of internal structures have hindered the progress of apicomplexan
cell cycle studies. Our project is built on an innovative concept of apicomplexan cell cycle organization, where
instead of following the traditional G1-S-G2-M/C sequence, the G1 phase of T. gondii cell cycle is followed by a
composite S/G2/M/C cell cycle phase that lacks clear phase transitions. The new view of apicomplexan cell cycle
may explain why, until now, the apicomplexan G2 phase was considered missing, why tachyzoites require
multiple cell cycle Cdk-related kinases (Crks) and why the complete sequence of cell cycle events had never
been established. Our main hypothesis is that parasite-specific Crk-Cyclin complexes engage novel protein
networks to coordinate spatially segregated, but concurrent events during an overlap of G2 phase, mitosis, and
budding. We will examine how T. gondii controls progression throughout this composite cell cycle phase while
maintaining the overall order of cell cycle events. To elevate the studies of apicomplexan cell cycles, we have
designed new tools: a ToxoFUCCISC cell cycle probe, and two checkpoint synchronization models. To test our
hypothesis, we will characterize the protein networks acting in G2 (Aim 1) and at the spindle assembly checkpoint
(SAC) (Aim 2) and explore each checkpoint mechanism in detail. Using our new checkpoint-based
synchronization approach, we will perform global profiling of the entry (TgCrk4-Cyc4-regulated G2/M) and exit
from mitosis (TgCrk6-Cyc1-regulated SAC) to generate the landscape of the composite S/G2/M/C cell cycle
period (Aim 3). Our study will address outstanding questions of apicomplexan parasite biology regarding how
parasites regulate their amplification in host cells. Our results will have an impact on studies across the
Apicomplexa phylum and lay the groundwork to uncover the cell cycle strategies that produce multiple progenies
per cycle (e.g., Plasmodium spp. and Cryptosporidium spp.).

Public health relevance
Narrative How apicomplexan parasites control highly divergent cell division is not well understood, but it is clear that the proper execution of the cell cycle program is critical to parasite numbers in the host and associated disease. In this proposal, we will investigate the molecular basis for cell cycle control in Toxoplasma gondii. Some of the essential factors identified in our studies are shared by other related pathogens, such as Plasmodium falciparum, which causes malaria and, therefore, has a broader impact on the field of studies.